Development of Long-term Intrathecal Romidepsin: A New Drug Candidate for SCI-Induced Spasticity

The goal of our proposed Small Project is to develop an intrathecal administrative approach using Romidepsin
in for the purpose of treating spasticity. This study includes efficacy and safety primary outcomes, and
mechanistic exploratory outcome measures. Results from this project will allow us to determine the longer-term
effectiveness of low-dose, chronic Romidepsin administration through an IT route, and general safety of this
translational approach.
We will carry out two objectives to address the goal of this project.
In objective 1 we will establish the effectiveness of low dose, chronic IT delivery of Romidepsin on H-reflex
hyperexcitability associated with post-SCI spasticity. We have previously shown that acute intraperitoneal (IP)
delivery of Romidepsin is effective in altering dendritic spine dysgenesis in spinal motor neurons, and that it
can effectively reduce nociceptive, sensory neuron hyperexcitability in a burn-inflammatory model. Additionally,
our preliminary data show that IP delivery of Romidepsin in SCI mice reduces H-reflex hyperexcitability.
Because spasticity is an ongoing, chronic disease, however, acute injectable systemic treatments have limited
clinical value. As such, we now seek to understand the efficacy and safety of long-term infusion using a
clinically relevant drug delivery method using the clinically established intrathecal catheter infusion method.
[In objective 2 To assess Romidepsin effectiveness with the IT route, we will compare spasticity and health
outcomes of SCI mice receiving IV treatment of Romidepsin—the currently established clinical delivery method
for T-cell lymphoma in humans (Yang, 2011). Here, Romidepsin will be injected into the lateral tail vein in mice
(i.e. IV infused). IV delivery carries the advantage of flexibility in that the drug delivery can be easily adjusted.
However, IV can lead to systemic side effects and has limited ability to cross the blood-brain barrier which
limits its efficacy for CNS injury and disease. Here, we will determine if IT or IV delivery of Romidepsin is
equivalent (or superior) in attenuating the underlying pathology, e.g., loss of rate dependent depression (RDD)
of the evoked H-reflex, of spasticity following SCI.]
In summary, this project will establish a translational low dose IT delivery system of Romidepsin directly to the
spinal cord following SCI (Objective 1). [It will also gather comparative data against spasticity treatment with
IV-infused Romidepsin following SCI (Objective 2).]

Public health relevance
Approximately 60% of US Veterans with spinal cord injuries (SCI) experience clinically significant spasticity, which can disrupt rehabilitation and negatively impact quality-of-life, e.g., mobility, personal hygiene, intimate relationships. Previously, we have found that intraperitoneal (IP) injection of the FDA approved compound Romidepsin (a PAK1 inhibitor) suppresses the H-reflex in mice SCIs. In this project we will determine whether intrathecal (IT) route administration of Romidepsin reduces H-reflex hyperexcitability following SCI, as well as dendritic spine dysgenesis. [To compare safety, efficacy, and side effects of IT delivery of Romidepsin to that of IV delivery of Romidepsin (standard clinical delivery method for T-cell lymphoma in humans).] Results from this project will allow us to determine the safety and efficacy of IT administration for translational studies of Romidepsin for treatment of spasticity following SCI.